In-depth characterization of the metabolic effect of the bacterial alamorne ppGpp

Project Summary
Bacterial cells are extremely efficient in adapting to environmental stresses. As a prime example, they synthesize
a second messenger called ppGpp in response to starvation. Accumulation of ppGpp in bacteria arrests growth
and reprograms cellular physiology to promote survival. These effects of ppGpp is required for antibiotic
persistence that allows bacteria to survive the treatment of antibiotics to which they do not encode genetic
resistance. At molecular levels, ppGpp reprograms gene expression, and targets many other proteins involved
in translation and small-molecule metabolism. As a preliminary study, I synthesized a photo-crosslinking probe
of ppGpp and used this probe to capture and identify about 30 new ppGpp-binding proteins in E. coli. Recently,
a ppGpp riboswitch has been discovered in Gram-positive organisms. Intriguingly, E. coli transcriptome has a
rich secondary-structure landscape, but the capability of these secondary structures in binding to small-molecule
metabolite has not been explored. Therefore, in Aim 1, I will use a photo-crosslinking approach to capture binding
partners of ppGpp from E. coli transcriptome, and identify these transcripts using RNA-seq. Hit interactions will
be validated biophysically, and their putative effects on translation efficiency or the transcript stability will be
examined in vivo. Additionally, in my preliminary study, I also compared metabolite profiles in E. coli before and
shortly after ppGpp induction, and found strong perturbation of dozens of essential metabolites. This perturbation
of cellular metabolism goes much beyond known direct effects of ppGpp. It is unclear how ppGpp induction
drives the inhibition of various metabolic pathways to effectively arrest bacterial growth and promote persistence.
In Aim 2, I hypothesize that “ppGpp-sensitive” metabolites, i. e., those whose levels perturbed by ppGpp
induction, serve as a proxy of ppGpp to regulate cellular metabolism. I will seek discovering protein-metabolite
interactions responsible for this indirect effect of ppGpp. To this end, I will use time-resolved metabolomics to
identify candidate metabolites and enzymes whose levels/activities perturbed contemporaneously with ppGpp
accumulation. I will then screen for protein-metabolite interactions among these candidates using an
ultrafiltration-based assay. Briefly, I will purify each protein of interest (POI) to high homogeneity. Then, I will
subject a mixture containing a library of all candidate metabolites and a single POI to ultrafiltration. Analyzing
the filtrate using MS should reveal a decrease of the POI’s cognate ligands. I will validate any novel interactions
identified using biochemical, structural, and genetic approaches. Together, the proposed research will explore
two new aspects of ppGpp signaling, namely RNA targeting and indirect effects on cellular metabolism via
ppGpp-sensitive metabolites. This study may lead to the discovery of key regulatory interactions required for
bacterial persistence, and these interactions may serve as targets for anti-persistence drug design.

Public health relevance
When suffering starvation, bacteria produce a universally conserved second messenger, ppGpp, which reprograms cellular physiology, arrests growth, and thereby enhances bacterial persistence against antibiotic treatment. By developing two innovative techniques to identify RNA-metabolite and protein-metabolite interactions, respectively, this proposal will examine the roles of small-molecule metabolites in coordinating various cellular activities in response to ppGpp induction. The proposed research will provide new insights on the mechanisms of ppGpp-mediated growth arrest, and elucidate key regulatory interactions required for bacterial persistence: these interactions may serve as targets for the design of anti-persistence drugs.